Top-Down Control of Selective Amplification

Human listeners depend on the sense of hearing to communicate effectively in everyday social situations.
Although we rely heavily on our ability to selectively attend to a single voice in a noisy background, and to follow
transitions in talkers during conversation, this task is quite complex and accomplishing it successfully depends
on the integrity of processing at a number of physiological sites spanning the auditory periphery to the brain. It
is well known that hearing loss may adversely affect a listener's ability to perceptually segregate one talker in
the midst of other talkers and to understand that talker's spoken message (i.e., the "cocktail party problem"; see
Middlebrooks et al., 2017, for a series of recent reviews). The most common remedy for sensorineural hearing
loss (SNHL) is a hearing aid, or a pair of aids, that can boost sounds to audible levels while preserving
comfortable loudness and may improve signal-to-noise ratio for certain classes of sounds via "noise reduction".
However, even when listeners with SNHL wear hearing aids they often still experience extreme difficulty
perceptually navigating the "auditory scene", severely limiting their ability to communicate effectively. One reason
is that, from an acoustic perspective, the designation of a particular sound source as "target" versus "masker" is
arbitrary because it depends on the current - and changeable - internal state of the observer. Thus, the distinction
between a target talker to be attended and a masker talker to be ignored can only be made by the listener and
may change from moment to moment. Although the amplification of sounds by hearing aids provides the best
(often the only) option for improving communication for listeners with SNHL, current hearing aids inherently fail
to solve the source selection problem because they amplify target and masker sounds indiscriminately without
the ability to distinguish which source the listener has chosen as the target. Thus the challenge is to devise a
hearing aid that focuses only on those sounds the listener chooses to attend and suppresses competing sounds,
responding to the wishes of the listener immediately, accurately, and effectively. During the past award period,
our work has demonstrated that acoustic beamforming implemented by a head worn microphone array can
provide a significant advantage for listeners with SNHL in solving the cocktail party problem. Furthermore, we
have found that steering the beam of amplification can be accomplished quickly and effectively by sensing eye
gaze with an eye tracker and directing the acoustic look direction (ALD) of the beam accordingly. The present
application requests support to continue work on this visually guided hearing aid (VGHA) and to further examine
the scientific premise upon which it is based. The overall goals are to better understand how top-down control of
selective amplification provides assistance to listeners with SNHL in typical social situations, to advance our
understanding of auditory and auditory-visual selective attention, and to extend the potential benefits of the
VGHA to new populations of listeners - users of bilateral cochlear implants and persons with aphasia - who
typically experience great difficulty understanding speech in complex, multiple-talker communication situations.

Public health relevance
Project Narrative The goal of this work is to design a better hearing aid. It allows the listener to select which sound source to amplify simply by looking at it and is called the "visually guided hearing aid." The aid depends on the coordinated actions of hearing and vision and how they work together to selectively attend to specific sounds such as one human voice in a background of noise or other voices.